Sleep Deficits induced by Alcohol

––– PROJECT SUMMARY / ABSTRACT –––––––––––––––––––––––––– Sleep Deficits Induced by Alcohol ––––
Alcohol use disorders (AUD) are a public health problem for which few effective treatments exist. Alcohol
drinking causes sleep disturbances, both acutely, as well as with chronic use. These long-lasting sleep deficits
are often ‘alleviated’ by drinking yet more alcohol, thus reinforcing a vicious negative cycle. A large fraction of
AUD patients in recovery will continue to experience sleep deficits, even after other physical withdrawal
symptoms have subsided. That fraction of abstainers is most at risk for relapse. Despite its obvious clinical
significance, very little is understood about the mechanistic links between alcohol consumption and the
development of long-lasting sleep deficits, and how these sleep deficits might be addressed to reduce
continued or relapsing alcohol use. This proposal aims to undertake a mechanistic investigation into the genes
and neurons that regulate alcohol-induced sleep deficits, with the long-term goal of finding interventions to
ameliorate these deficits. We use Drosophila as a model organism because of its economy of scale and face-
valid behaviors, i.e. alcohol responses that ‘look like’ those in humans. We propose to build on our substantial
foundational data showing that sedating alcohol exposures lead to long-lasting sleep deficits for days after
alcohol exposure and clearance. This includes loss of total sleep amount, especially at night, an increase in
sleep latency, which means that it takes flies longer to fall asleep after lights out, and poor sleep quality — all
recapitulating human phenotypes. In Aim1 we will investigate behavioral correlates and predictors of alcohol-
induced sleep deficits. In Aim2 we will investigate the genetic mechanisms of ethanol-induced sleep deficits
based on our preliminary data from three genes, generated using three orthogonal approaches. We will
investigate the role of the insulin receptor signaling pathway, which we have previously shown to regulate
behavioral responses to alcohol. We will also test 216 candidate genes associated with sleep phenotypes in
humans for their role in alcohol-induced sleep deficits. In Aim3 we will determine neurons and circuits that
mediate ethanol-induced sleep deficits, based on our preliminary findings that different neurons have distinct
effects on ethanol-induced sleep deficits. This necessary step will allow us to address mutants’ pleiotropy,
affecting multiple alcohol responses, and it also paves the way to investigate the molecular changes induced
by alcohol that might mediate persistent sleep deficits. Together, these data will provide first mechanistic
insights into the long-lasting sleep deficits that are induced by alcohol. Because these deficits pose a
significant risk factor for continued and relapsing alcohol use, our mechanistic investigation will also suggest
potential interventional strategies.

Public health relevance
––– PROJECT NARRATIVE –––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––––– Alcohol abuse disorders are a chronic human condition where initial consumption leads to long lasting behavioral changes, including tolerance to repeat exposure and sleep deficits, both of which are drivers of continued alcohol use. The results of the proposed studies will provide valuable mechanistic insight into the genetic, and neural mechanisms that link alcohol exposure with changes in sleep patterns. This will highlight novel targets for therapeutic intervention in alcohol addiction, which are largely lacking.